Real-time Predictors of Prescription Drug Misuse by College Students and Assessment of Misuse on Their Developmental Trajectories

PROJECT SUMMARY/ABSTRACT There is no change to the project summary/abstract.

Public health relevance
PROJECT NARRATIVE There is no change to the project narrative.